MACS/WIHS Combined Cohort Study: Cook County Clinical Research Site (CC_CRS) - OAR Sleep Supplement

ABSTRACT
The objective of this supplement application is to investigate targeted kynurenine (KYN) pathway metabolites
as molecular mechanisms by which objectively measured habitual sleep and circadian disruption increase risk
for HIV-associated cardiometabolic disease and to determine whether these relationships differ by biological
sex and HIV disease status. We will measure targeted KYN pathway metabolites in stored plasma (n=800)
from well characterized MACS/WIHS Combined Cohort Study (MWCCS) men who already have habitual sleep
measures collected, validated, and systematically scored via one week continuous wrist actigraphy (Philips
Respironics Actiwatch Spectrum Plus). There will be no MWCCS participant and field staff burden for this
supplement. No study to date has examined KYN pathway activation as a mechanism linking sleep and
circadian disruption to HIV-related and inflammatory mediated comorbidities such as cardiometabolic disease
in a mixed sex sample nor has this been accomplished with representation across all HIV disease status
groups (well and poorly controlled HIV with comparison to uninfected controls). Results will provide novel
insights into biological sex and HIV disease status differences in the mechanistic relationships between sleep
and circadian disruption, KYN pathway activation, and HIV-associated cardiometabolic disease and provide a
strong foundation upon which to test targeted sleep and circadian interventions to reduce risk for HIV-
associated comorbidities in men and women aging with HIV.

Public health relevance
PROJECT NARRATIVE Despite combination antiretroviral therapy (cART) for HIV, chronic inflammation persists, increasing risk for cardiometabolic disease. The tryptophan-kynurenine (TRP-KYN) pathway is a molecular mechanism that is activated by HIV and inflammation, and increases risk for cardiometabolic disease. In a mixed sex sample of persons with HIV (PWH) both virally suppressed and unsuppressed, and matched uninfected controls, this supplement will examine sleep and circadian disruption as an additional trigger of the TRP-KYN pathway, thereby linking sleep/circadian disruption to a greater risk for HIV-associated cardiometabolic disease.